LONGITUDINAL STUDY OF EFFECT OF VIRAL INFECTIONS ON ASTHMATIC CHILDREN

Viral respiratory tract infections are well known to trigger wheezing in asthma in children and adults with asthma. The proposed mechanism by which this occurs is unknown. The role of T-cells in viral immunity in the asthmatic airways has not been previously studied. The T-lymphocyte may play a key role in the inflammatory cascade of events in virus-induced asthma. We hypothesize that T-lymphocytes subpopulations may behave differently in the setting of virus-induced asthmatic exacerbations.